Utah Center for Clinical and Translational Science

Contact PD/PI: Dere, Willard H.
ABSTRACT - OVERALL
The University of Utah Center for Clinical and Translational Science (CCTS) serves as the central locus of
translational research in the Intermountain West. The CCTS has become the center for combining the efforts of
the University of Utah and its partners into a vibrant research enterprise which advances both clinical projects
and the science of translational research. To realize these goals, the CCTS is led by Co-Principal Investigators
Drs. Dere and Hess, who are well positioned within institutional leadership and are supported by a variety of
institutional initiatives and resources that complement the CCTS activities. The Co-PIs are supported by an
integrated group of experienced local, regional, and national leaders and are guided by a comprehensive
oversight structure that anchors the CCTS within the University of Utah and its partners. Our proposal builds
on a firm foundation of achievements in areas of strength which include but are not limited to: our genetics
programs, which has led to discoveries of numerous disease-causing genes and to a variety of software
platforms that are used in computational genomics globally; our community-outreach efforts, highlighted by
state- and nationwide initiatives by key leaders; our statistical methods and software developed to evaluate
surrogate markers; and our substantive experiences in clinical trials, both traditional randomized and
pragmatic, and multi-center collaboration networks, which continue to study a variety of special populations
identified by the recent NCATS Lifespan initiatives. By supporting successful trainees at all levels and
preparing them for productive careers, we are building a diverse workforce able to use our extensive
infrastructure to advance national CTSA goals. The breadth of the CCTS activities allows it to address
established and emerging institutional issues by providing timely resources, advice, and services. We look
forward to addressing major public health and translational research issues through a comprehensive suite of
services, as well as a culture that prizes team science and high quality research in order to better ensure
research reproducibility. We seek to achieve our goals through four specific aims: (1) Catalyze clinical and
translational research as the CTSA hub for the Intermountain West; (2) Advance and refine an educational
environment that maximizes the value of collaboration and training among various stakeholders; (3) Integrate
diverse partners for meaningful collaborations in research endeavors across the translational spectrum; (4)
Promote efficient and effective data collection, analyses, and sharing that leverages innovative informatics-
based solutions.
Project Summary/Abstract Page 282
Contact PD/PI: Dere, Willard H.

Public health relevance
PROJECT NARRATIVE The University of Utah Center for Clinical and Translational Science (CCTS) is part of a state-wide, regional, and national network of biomedical research teams that ensure collaboration and information exchange that improves public health. The Utah CCTS has established a strong infrastructure to support translational research projects and train health care professionals. It is committed to disseminating research findings to health care and lay communities, locally and nationally, in a timely manner. Project Narrative Page 283